SUSTAIN: Advancing Makerere University Masters of Health Sciences in Bioethics

ABSTRACT
This is a renewal application to the previous International Health Ethics Training program award
(R25TW009730 PD Nelson Sewankambo), that is currently in a no-cost extension period till
December 2019. The program has focused on increasing capacity mainly at Master’s degree level and
short courses for professionals, researchers and students. This new application is entitled, “Sustain:
Advancing Makerere University Masters Bioethics training”. Its major focus is sustainability and builds on
the achievements, challenges and lessons learned from the above program, while taking into consideration
a) the rapidly increasing external research funding in Uganda b) the increasing focus on research ethics
education at masters, PhD and post-doctoral levels, c) the improved national and institutional regulatory
research ethics mechanisms and d) the more than 30-year longstanding research collaborations between
Ugandan and foreign researchers.
The overall goal of this application, led by Prof Nelson Sewankambo at Makerere University is to implement
a sustainable advanced masters level education that provides in-depth understanding of international
research ethics in clinical, biomedical, behavioral and public health research, and enhances application of
research ethics principles in the East Africa. The program objectives that align with the three domains
mentioned above are:
1. To develop and sustain a two-year advanced Master of Health Science in Bioethics anchored on
didactic course work and practicum experiences to produce graduates who are life-long learners, with
in-depth knowledge and advanced skills that are scientifically and socio-culturally relevant to Uganda
and international research ethics to provide research ethics leadership (in education, service provision,
policy development, and conduct of applied and empirical research.
2. To develop and institutionalize a mentorship program in research ethics that facilitates development of
bioethics professionals and health researchers who are committed to the growth and application of
research ethics in Uganda’s academic and research institutions to the highest possible degree.
3. To accelerate the development of a Bioethics Center at Makerere University College of Health
Sciences, that will serve as a coordination and innovations hub for the rapidly increasing and expanding
ethics education (including continuing ethics education and mentorship to alumni), research,
consultancy services, policy and related partnerships and networking activities at this research intense
institution.
This renewal application will lay a firm foundation for sustainability of model program for Uganda and the
Sub-Saharan region. Candidates for admission will be identified through a rigorous three-step process. A
Training and Advisory committee will be composed of leading researchers, bioethicists, educators and
policy makers from Makerere University. They will work closely with the implementation team to ensure
success of each trainee and the overall program. This process will lead to enhanced education, training
and professional development of its graduating bioethicists with potential to become research ethics
leaders and life-long learners. The students will each complete a mentored research project, disseminate
their results widely in the country and internationally including publishing in peer-reviewed journals. The
success of this program will translate into improvements in ethical decision making for research leading to
enhancements in responsible conduct of research, and overall protection of research participants.

Public health relevance
NARRATIVE The proposed program will develop a sustainable, model master’s degree program in international research ethics based at a strengthened Bioethics Center at Makerere University to produce graduates with potential to become bioethics leaders. Bioethics will become a significant part of their career participating in education of the next generation of bioethicists, design and implementation of high-quality ethical health research, conduct bioethics research, and provide expert advice to researchers, and policy makers. The success of this program will translate into improvements in ethical decision making for research leading to enhancements in responsible conduct of research, and overall protection of research participants.